Advancing Protein Isoform Analysis through an Integrated Computational Framework.

PROJECT SUMMARY
Over 90% of human genes undergo alternative splicing, generating numerous transcripts or isoforms with
distinct functions for each gene. This highly regulated process is often disrupted in cancer, leading to the
production of harmful protein isoforms that contribute to tumor growth, survival, metastasis, and immune
evasion. Accurately identifying these aberrant isoforms is essential for understanding cancer biology and
developing targeted therapies. While RNA sequencing has advanced our understanding of alternative splicing
in cancer, the study of protein isoforms at the proteomic level is still in its infancy. Advances in mass
spectrometry (MS)-based shotgun proteomics have enabled unbiased identification and quantification of more
than 10,000 protein coding genes from biological samples. However, because shotgun proteomics data
analysis involves searching MS spectra against a reference protein database to identify peptides, and most
identified peptides map to multiple protein isoforms, it remains challenging to accurately identify and quantify
known protein isoforms in the reference database. Furthermore, novel isoforms absent from the reference
database cannot be identified. Efforts have been made to address these challenges, such as the development
of our recently published SEPepQuant algorithm, but integrating known and novel protein isoform identification
and quantification into routine cancer research remains elusive. This integration faces two primary hurdles.
Firstly, there are software-related obstacles in protein isoform identification and quantification, including the
lack of user-friendly tools, insufficient benchmarking to guide software selection, difficulty in result interpretation,
and compatibility issues with rapidly evolving MS technologies. Secondly, even with advanced software, its
usage is confined to bioinformaticians, limiting direct benefits for most biologists and clinicians to gain insights
into protein isoforms from the wealth of public cancer proteomic datasets. The overarching goal of this project
is to overcome these hurdles by developing an integrated computational framework for shotgun proteomics-
based protein isoform analysis and facilitating the dissemination of protein isoform data through accessible
platforms. Leveraging the complementary expertise and unique resources of our investigator team, we will
achieve this goal through three specific aims: Aim 1) Further develop SEPepQuant to improve robustness,
interpretation, compatibility, and proteogenomic integration; Aim 2) Create a unified framework for protein
isoform quantification and conduct systematic benchmarking; and Aim 3) Democratize protein isoform analysis
for ordinary biologists and clinicians. Through these aims, we will create new informatics technologies to
advance protein isoform analysis in cancer research, enhancing our understanding of protein isoform
regulation, and facilitating the identification of dysregulated isoforms as potential biomarkers and therapeutic
targets.

Public health relevance
PROJECT NARRATIVE Alternative splicing, a process where genes create different versions of proteins, is crucial for normal cell function. In cancer, this process often goes awry, leading to the production of harmful proteins that fuel tumor growth and spread. Our project aims to develop novel informatics tools to comprehensively understand these aberrant proteins, with the ultimate goal of facilitating the discovery of novel biomarkers and the development of precisely targeted therapies for cancer patients.